Administrative Core

Project Summary
The University of Alabama at Birmingham (UAB)-University of California at San Diego (UCSD) O'Brien
Center for Acute Kidney Injury (AKI) is designed to provide scientifically rigorous, state-of-the-art methodologies
in a cost-effective manner to foster investigations that will (i) continue to attract new scientific expertise into the
study of the basic mechanisms of kidney diseases, specifically AKI; (ii) encourage interdisciplinary research; (iii)
explore new basic areas with translational potential; (iv) generate Pilot and Feasibility studies that provide new
and innovative approaches to study kidney disease; and (v) apply scientifically rigorous, state-of-the-art
methodologies in a cost-effective manner to address experimental questions to advance understanding of the
pathophysiology of AKI. The Administrative Core will coordinate and integrate the diverse activities of the UAB-
UCSD O'Brien Center, facilitate interactions and collaborations among the research base, ensure quality control,
rigor and reproducibility of the core services and promote scientific development. The Administrative Core
includes a Biostatistical Resource (BR), which will provide statistical support for the cores and research and pilot
projects of the O'Brien Center.
The administrative structure with clear lines of authority has been developed to ensure that the goals and
objectives of the Center are achieved. The Director and Associate Directors will be advised by an Internal
Advisory Committee, who were carefully selected based on their experience in directing high quality large
research programs and include the Directors of the Clinical and Translational Science Awards (CTSA) at both
UAB and UCSD. In addition, the Center leadership will be advised by an External Advisory Committee, a Pilot
and Feasibility (PAF) Program Committee and a Scientific Advisory Committee for each Core.
The Administrative Core will continue to oversee the PAF Program and will be responsible for evaluating
the Pilot Program's efficacy in promoting high quality AKI-related research that leads to extramural funding and
publications. In addition, the Administrative Core will organize and support an Enrichment Program consisting of
symposia, seminars with visiting speakers, journal clubs/work-in progress sessions, interface with CTSA
enrichment programs, Summer Students Training Program, and an Annual Comprehensive Research
Symposium. The Administrative Core has also established a communication network through email, newsletters,
live video conferencing and a website to inform Center investigators of the activities and funding opportunities,
AKI-related news, as well as the availability of new reagents and technologies through the Center. Therefore,
the Administrative Core will enable optimal coordination of the various Center components through its
committees, regularly scheduled meetings, seminar series, web-based communication mechanisms and video
conferences between participating institutions.